TIPS: Training in Perioperative Science

The training program open to MDs typically at the end of their residency training is designed to provide
2 years of research training in perioperative science. The major goal of this training program is to
provide the highest caliber research training to residents and postdoctoral fellows in four Specific
Themes originating from existing strengths of our faculty within Anesthesiology and at Vanderbilt
University Medical Center: 1) Mechanisms and Management of Pain; 2) Perioperative Stress Biology and
Outcomes; 3) Perioperative Health Services and Translational Research; and 4) Personalized Medicine
and Pharmacogenomics. Each of these themes directly relates to the overarching aim of the program –
to train the next generation of scientists to create new knowledge and translate it into best evidence for
personalized perioperative care and pain management at a population level. The training faculty will
consist of an exceptionally strong collection of physician‐scientists and basic scientists who offer superb
interdisciplinary research training opportunities in 7 different academic departments. The training
program will accept two new trainees per year (staggered, maximum of 4 participants per year).
Clinicians who show exceptional aptitude for successfully pursuing an academic research career and
Ph.D. who demonstrate best aptitude to develop towards independence will be considered for
participation. Each participant will commit to a 2 year basic science, clinical and/or translational
research project with 75% effort and will receive over the 2 year period in addition to their research
project training, coursework training in research related processes such grant writing, publications,
ethics, and responsible conduct of research. This training will prepare them to utilize the skills they
acquire in the pursuit of future academic research careers.

Public health relevance
Project Narrative This training program in basic, clinical, and translational research will train basic and physician scientists in mechanisms and management of pain, perioperative stress biology and outcomes, health service and translational research, and personalized medicine and pharmacogenomics. The program will prepare future researchers for the unique challenges associated with the optimization of perioperative care.